Intracellular Signaling by Bacterial Chemoreceptors

not needed for an administrative supplement request; see parent grant for the info.

Public health relevance
not needed for an administrative supplement request; see parent grant for the info.